A Uniquely Scalable Approach to Single Cell Sequencing for the Development of Next Generation Cell Therapies

Immunotherapies (including CAR-T cell therapies) are wonder drugs when they work, but the
response rates of today’s immunotherapies are only 15-20% and therapy costs remain
prohibitively high for mass adoption. Single-cell sequencing (SC-seq) is becoming the preferred
tool for immune profiling to map a patient’s adaptive immune response, and to readout phenotypic
changes that result from CRISPR based gene edits at the single cell level. However, the full
potential of SC-seq based CRISPR screens and immune repertoire profiling for the development
of next generation therapeutics requires a 10-fold to 100-fold increase in cell throughput relative
to current platforms. Upcoming expiration of Illumina’s core IP re-ignited competition in US & EU
markets. The resulting re-acceleration in the drop of DNA sequencing costs (6-fold price reduction
in 2023 vs. Illumina’s 2022 pricing) makes SC-seq of 10 million cells affordable today (20-30
million cells in ~3 years and 100 million cells in 6 years), but existing methods for SC-seq do not
support throughput beyond 1 million cells per experiment. Proposed alternatives are scalable, but
trade-offs in performance and ease-of-use make them unsuitable for translational research.
Sansimeon’s approach uniquely scales SC-seq with throughput >100M cells, while retaining the
ease-of-use and necessary cell capture efficiency for high-throughput applications in translational
research. Our platform incorporates a technology for in-line sample debulking, which was
previously commercialized for applications in cell therapy manufacturing and rare cell isolation.
Sansimeon’s ability to sequence >100 million single cells directly from crude & complex samples
(such as whole blood or bone marrow aspirates), with a single-step automated workflow, makes
the platform ideally suited for high-throughput applications in translational research.

Public health relevance
The ability to sequence 10 million - 100 million single cells per experiment will enable researchers to develop the next generation of cell therapies to treat cancer with greater efficacy at reduced cost. Existing methods for single cell sequencing do not support throughput beyond 1 million cells per experiment, and alternative approaches to scale single cell sequencing are unsuitable for translational research due to trade-offs in performance and ease-of-use. Sansimeon’s approach uniquely scales single cell sequencing with throughput >100M cells, and our streamlined workflow to sequence cells directly from crude & complex samples (such as whole blood or bone marrow aspirates), with a single-step automated workflow, makes the platform ideally suited for high- throughput translational research applications.